IND-enabling studies of KTX-1161, a novel NRF2 activator for corneal endothelial disease

ABSTRACT
This proposal by Kuria Therapeutics seeks to conduct IND-enabling studies of KTX-1161, a topical eye drop
intended to protect corneal endothelial cells (CECs) during cataract surgery and to treat Fuchs’ endothelial
corneal dystrophy. KTX-1161 contains the active ingredient SCO-116 which is a proprietary small molecule that
activates NRF2. NRF2 is a transcription factor that initiates protective cellular defense systems against oxidative
stress, mitochondrial dysfunction, and inflammation. The KTX-1161 eye drop should act to protect against the
oxidative insult from phacoemulsification and the chronic oxidative stress inherent to Fuchs’ dystrophy.
Three Specific Aims in this proposal will achieve the overall goal of completing the IND-enabling nonclinical
requirements in preparation for first clinical studies of KTX-1161. In Phase I, Aim 1 is to conduct the GLP
genotoxicity study package typically required by FDA for small molecules. Studies include the Ames test, in vitro
chromosome aberration assay, and an in vivo micronucleus test in rats to determine the genetic toxicity potential
of SCO-116. In Phase II, Aim 2 includes conduct of the FDA-required GLP safety pharmacology program, an
ocular pharmacokinetic study, and the typical GLP oral and ocular toxicology studies. For safety pharmacology,
a rat respiratory study and hERG test will be performed. A rabbit ocular PK study was specifically requested by
FDA and will be done. The rat oral and dog ocular toxicology studies will be the normal 28-day toxicology designs
with the addition of detailed observations to the rat oral study as requested by FDA during a 2023 pre-IND
meeting. Aim 3 comprises the writing of the nonclinical section of the IND which will include the nonclinical study
reports supporting SCO-116 safety and efficacy and the written and tabulated summaries.
CEC loss occurs in virtually all of the ~4 million cataract surgeries done each year in the US, with about half a
million patients experiencing excessive CEC loss. With KTX-1161, Kuria aspires to reduce the number of
excessive CEC losses and reduce the magnitude of average CEC loss, protecting the future vision of all patients.

Public health relevance
NARRATIVE KTX-1161 is a topical eye drop to be used before and after cataract surgery for the prevention of corneal endothelial cell (CEC) loss and chronically to treat Fuchs’ dystrophy. Kuria Therapeutics is developing this product which contains an NRF2 activator that initiates cellular defense systems to protect delicate CECs from oxidative stress. Commercialization of KTX-1161 could protect sight for millions of Americans.